The Interplay of ENDS and Tobacco Control Policy: Impact on the Population Harms of Tobacco

Project Summary
This project will clarify the value and impact of policy options intended to reduce the population harms of
tobacco. The rise in popularity of electronic nicotine delivery systems (ENDS) such as e-cigarettes poses both
opportunities and challenges for reducing the population harms of tobacco. ENDS might reduce population
harm if substituted for a significant proportion of combustible cigarettes (c-cigs), but such benefits must be
weighed against the fact that ENDS pose a risk to individuals who, in their absence, would not use tobacco.
Simulation studies can and have been used to assess the trade-offs associated with ENDS. To date, effects
have been simulated in the context of tobacco control policy that was in place at the time the model was built
and reflect the average of state policies in place. Yet, the effects of ENDS may vary according to the intensity
of the tobacco control policies in place. For the proposed study, we define intensified tobacco control policies
(I-TCP) as evidence-based policies that primarily target c-cig use and are capable of substantially reducing the
population harms from tobacco when scaled to levels recommended by public health agencies, i.e., c-cig
taxes, increased tobacco control expenditures that fund comprehensive tobacco control programs, and
comprehensive indoor smoking bans. Because I-TCP can substantially reduce the population harms of
tobacco, the potential for ENDS to further reduce these harms may be attenuated when I-TCP are in effect.
Moreover, our current knowledge of the health and economic impact of I-TCP was, for the most part, amassed
during a time when ENDs did not exist. If the presence of ENDS in the marketplace leads to substitution of less
harmful forms of nicotine (such as ENDS) for more toxic combustible products, then, given the widespread
availability of ENDS, I-TCPs may not lower population health and economic harms of tobacco as much as
available estimates indicate. I-TCP may also influence use patterns of ENDS, creating dynamics that could
lead to unanticipated levels of health impact for both ENDS and I-TCP. Thus, the introduction of ENDS to the
marketplace has created gaps in our knowledge of policy effects, which could precipitate policy missteps that
increase, not decrease, population level tobacco harm. The intertwined effects of tobacco products and
policies cannot meaningfully be explored through any real-world experiment. Therefore, we will conduct a
simulation study to close these knowledge gaps. Although no state is implementing all tobacco policies at
recommended levels, existing variation in state policies can be exploited to reveal the likely impact of individual
state policies. Leveraging existing data sets that capture variation in state policy timing and intensity, we will
build a simulation model to estimate the combined effects of policies and ENDS. Model simulations will
produce both national- and state-level estimates to inform policy aimed at reducing tobacco population harms,
while accounting for: the effects of ENDS in the presence or absence of I-TCP, and the effects of I-TCP in the
presence or absence of ENDS. The results will clarify the plausible range of impacts of both ENDS and I-TCP.

Public health relevance
Project Narrative The popularity of e-cigarettes and other electronic nicotine delivery systems (ENDS), especially among youth, is compelling policymakers to reengineer tobacco control policy and is reigniting the debate on whether to accept ENDS for tobacco harm reduction or to apply the precautionary principle to ENDS. The level of reduction in population level harms conferred by ENDS may depend on the policy context, and likewise, the presence of ENDS in the marketplace may alter the impact of tobacco control policies on population level harm. This study will develop the first state-level microsimulation model to estimate the health and economic impact of intensive tobacco control policies, under scenarios with and without ENDS in the marketplace, in order to: 1) estimate the magnitude of the effect that ENDS presence has on a policy’s effect in reducing population harms of tobacco and 2) estimate the variation in population level harms attributable to ENDS over alternative policy contexts.